MINIATURIZED INSTRUMENT FOR TOTAL CELL DNA ANALYSIS

A unique approach for the construction of an automated microchannel flow cytometer for quantitative analysis of high-brightness fluorescently stained cells or nuclei is presented.